Exploring the Applicability of Potential Negative Allosteric Modulators at the Mu Opioid Receptor

Project Summary/Abstract
We are experiencing the third wave of opiates, a shift to powerful synthetics that is mirrored in other drugs of abuse such
as cannabinoids (Spice) and cathinones (‘bath salts’). These potent drugs are preferred by dealers for economic reasons, but
many of the new synthetic opiates bind so tightly to their target receptor, that the current treatment (naloxone/Narcan) for
opioid overdose can prove ineffective. There are police reports of victims of synthetic opiate overdose found with multiple
expended doses of naloxone, or who need IV administration. In the case of fentanyl-associated ‘wooden chest syndrome’,
even a trained CPR provider cannot prevent death by asphyxiation. Where a competitive antagonist struggles against
carfentanyl, a negative allosteric modulator may succeed. These molecules act via secondary sites on the receptor. Two
candidate compounds have been identified; we hypothesize that negative allosteric modulators at the mu opioid receptors
(µORs) can serve as an alternative strategy to overcome potent synthetic opiates, with the goal of alleviating the fatality of
opioid toxicity. The project involves an iterative series of tests of structural analogues of these candidate negative allosteric
modulators for their ability to reverse opiate signaling both in vitro and in vivo. The goal is to develop an optimized negative
allosteric modulator at the µOR that would reverse opiate overdose in an emergency setting. Due to the nature of allosteric
modulators, there is reason to expect that this would also avoid the strong withdrawal symptoms elicited by naloxone in
opiate-dependent individuals, which is also an advantage in an emergency setting. Such a compound may also have superior
pharmacological properties to naltrexone in places where methadone/buprenorphine are unavailable. With the current
climate of the opioid crisis, it is crucial to explore the implications of the negative allosteric modulators, as it could lead to
an alternative antidote to the increasingly powerful opiates that are being seen.
Indiana University is a large university with a strength in biological research and particularly in drugs of abuse such as
cannabinoids and opiates; the university also features many scientific resources (e.g. core facilities) to support research.
The neuroscience program is highly interactive thanks in part to the Gill Center that sponsors an annual Symposium, visiting
speakers, and a journal club. A training plan has been developed that covers techniques (in vitro and in vivo assays),
coursework, training in the responsible conduct of research, as well as mentorship in some of the less tangible, but
nonetheless essential, qualities that make for a successful scientist.

Public health relevance
Narrative Most of the recent rise in opioid overdose mortality is due to synthetic opioids, with there being an estimated 70,000 deaths in 2019 alone in the United States. Synthetic opioids, particularly the potent analogues of fentanyl (e.g. carfentanyl) bind tightly to opiate receptors, enough that the standard antidote naloxone can prove ineffective. An alternative to naloxone that works non-competitively may offer an effective strategy against this new wave of extremely powerful synthetic opiates.